Postdoctoral Training Program in Genomic Medicine

This is an application for a new Postdoctoral Training Program in Genomic Medicine (T32). We propose two postgraduate positions per year to support physician-scientists who are engaging in medical genetics research. There are too few medical geneticists to meet the growing need for our services. As a result, much of medical genetics testing, diagnosis, counseling, and management occurs outside of our field and is instead practiced by physicians who receive little specific training. Our goals are therefore twofold: first, to mentor future medical geneticists who are embarking on a career in academic medicine and therefore grow the medical genetics workforce; and secondly, to provide medical genetics training to physician-scientists in other fields who engage in medical genetics-related research, which will enhance the clinical knowledge-base of those specialists who may be most likely to use genetic testing or treatments in their practices. The specific aims of this proposal include: 1) protected mentored research experiences with well-established investigators performing research in medical genetics within the Washington University School of Medicine, 2) obligatory educational programs in laboratory management, scientific rigor, statistics, grantsmanship, responsible conduct of research, and biomedical informatics 3) individualized specific coursework based on the trainees’ areas of investigation, 4) continuous feedback to the trainees, mentors and program leadership, and 5) the development of trainees. Trainees may choose from four focus areas, which represent patient care needs with particularly rapid growth: Cancer, Rare and Undiagnosed Diseases, Gene-Environment Interaction, and Neurodegeneration. The program director, Patricia Dickson, will work closely with co-director Jorge Di Paola to select and oversee training of future leaders in genomic medicine. Major strengths of this program include active medical and laboratory genetics training programs, in-house clinical cytogenetics laboratory, biochemical laboratory, and sequencing capability, a large number of centers and groups performing genomic studies, including Undiagnosed Diseases Network clinical and model organism screening center sites, the McDonnell Genome Institute, the Cancer Atlas Network, the Edison Family Center for Genome Sciences & Systems Biology, and others. Washington University provides an outstanding mentorship environment and infrastructure for genetics research, with an emphasis on collaboration and a superb track record of producing physician-scientists. This proposal will take advantage of the wealth of genetics research, clinical and research training, and mentorship that is thriving on our campus to train those scientists who will bring innovative diagnostics, therapeutics, and data-driven practice to the clinic.

Public health relevance
PROJECT NARRATIVE Advances in genomic technology are transforming medicine, but there are too few physicians training in medical genetics today. This program will provide training in medical genetics and genetics research to physician scientists, to grow the genetics workforce in the four areas where science is progressing the fastest: cancer, rare diseases, gene-environment interactions, and neurodegeneration.